Training in Translational Lung Biology and Pathobiology

PROJECT SUMMARY
This competing renewal of a training program is designed to prepare highly qualified postdoctoral fellows for
research leadership careers in translational lung biology and lung disease relevant research. To ensure the most
competitive program, we seek applications from MD and PhD candidates from a wide range of sources and a
wide variety of scientific, personal, racial and ethnic backgrounds emphasizing a nationwide competition. This
program has been highly successful since its inception 25 years ago, and in this renewal, we have maintained
our focus on training in fundamental areas relevant to lung injury, immunology, and repair. We did, however,
continue to adapt to the needs of pulmonary research in the second decade of the 21st century and facing forward
the 3rd decade. Specifically, we continued our efforts to augment training in investigative efforts that will foster
human and translational investigations, especially training in cutting edge approaches including genomics and
high throughput profiling technologies, bioengineering, genome editing, computational biology and
bioinformatics, epidemiology, outcomes research and implementation science with a focus on enhancing
scientific rigor and reproducibility. MD trainees may enter this program only after having completed the clinical
requirements for Board eligibility. Optimal research training is achieved by protecting the trainees' time to allow
their efforts to be dedicated to research. Training is mentor-based, interdisciplinary, and enriched by didactic
courses and by interactions with diverse faculty who are recognized experts in their fields. Mentors are chosen
based on proven ongoing quality and productivity of their research programs, significant extramural support, and
availability and commitment to serve as mentors. The mentors are amongst the leaders of Yale research and
belong to research spheres identified as important in respiratory disease processes including: Translational
Research, Genetics and Genomics, Computational Biology and Informatics, Immunology and Inflammation,
Cellular and Molecular Physiology and Biology, Pathology, Stem Cell Biology and Repair, Vascular Biology,
Host-Pathogen Interactions and Dysbiosis, Biomedical Engineering, Clinical Epidemiology, Biostatistics, Clinical
Research and Implementation Science. Because of the wide spectrum of outstanding laboratories at Yale, the
institutional nature of this proposal, and the significant growth in the research funding and productivity at the
section of Pulmonary, Critical Care and Sleep Medicine at Yale, 10 positions are requested per year. The
program will be a minimum of 2 years. Trainee progress will be carefully evaluated and productivity monitored
by each mentor, a Research Advisory Committee, and the Program Directors. The uniqueness of this program
stems from a) the truly institutional nature of this grant involving 5 Schools at Yale, 9 clinical departments and 8
basic science departments; b) the strong interactions that exist between the clinical and basic science faculty on
this program; and c) the training track record of the mentors.

Public health relevance
PROJECT NARRATIVE / RELEVANCE Disorders of the respiratory tract continue to be a major cause of morbidity and mortality, affecting tens of millions of people. Effective treatments are lacking or suboptimal due to our lack of understanding of the disease pathogenesis and a pool of scientists too small to meet the research needs. This grant will prepare MD and PhD scientists with superior training in areas relevant to lung biology and lung disease and equip them to be leaders in their selected field of research.